A Novel N-of-1 Randomized, Controlled, Clinical Trial to Assess the Effect of Blenderized Tube Feeds on Esophagogastric Physiology

PROJECT SUMMARY
The fragile population of children with medical complexity (children with congenital or acquired multisystem
disease, neurologic impairment and/or dependence on medical technology) accounts for up to one third of all
pediatric medical expenditure. Systematic investigation of the contribution of nutrition to chronic disease burden
in this population has not been done and is urgently needed, as it has vast potential to optimize clinical outcomes
such as feeding intolerance, improve quality of life and reduce healthcare cost. Dr. Bridget Hron is a pediatric
gastroenterologist and nutrition specialist with advanced training in the nutritional regulation of metabolism and
inflammation who is perfectly suited to address this critical unmet need. Her career goal is to direct a clinical
research program focused on discovering evidenced-based, state of the art nutritional interventions that
transform the clinical care of the most vulnerable pediatric population.
In Dr. Hron's recent work, she has shown that blenderized diets, which are pureed high quality table foods such
as fruits, vegetables, meat and legumes administered via gastrostomy tube have a beneficial effect on health
care utilization, reducing admissions for pulmonary reasons by 53%. Over the course of this career development
award, Dr. Hron will study the effect of blenderized feeds varying in viscosity on gastrointestinal symptoms and
on esophageal and gastric function. The innovative aggregate randomized, controlled N-of-1 study design
outlined in this proposal allows each individual participant to determine diet of maximal efficacy, but also allows
for estimation of population effect of the interventions.
The exceptional mentorship and original scientific training proposed in this career development award are critical
for Dr. Hron's academic development. Dr. Rachel Rosen, primary mentor, is an expert in aerodigestive medicine,
and Dr. Christopher Schmid, co-mentor, is an expert in biostatistics with a focus on N-of-1 trials – both have
outstanding backgrounds in clinical research with deep commitment to mentorship. She will be supported by her
Scholarship Advisory Committee consisting of Drs. Wayne Lencer, Christopher Duggan, Jay Berry and Sharon
Donovan, who lend content-area expertise. Her formal training will include a Master of Science: Concentration
in Food Science at University of Illinois Urbana-Champaign, advanced courses in statistical analysis at the
Harvard T.H. Chan School of Public Health (HSPH), personal instruction on mediators of esophageal and gastric
motility by Dr. Rosen, and professional development courses through HSPH and Harvard Catalyst. Her training
and research activities will be conducted in the unparalleled academic environments of Boston Children's
Hospital and Harvard Medical School, which are firmly committed to Dr. Hron's successful transition to an
independent research career.

Public health relevance
PROJECT NARRATIVE Children with medical complexity who require enteral feeding support are a significant driver of total pediatric health care expenditure, with high rates of gastroesophageal reflux and feeding intolerance that are exacerbated by conventional enteral formulas. We hypothesize that blenderized diets (pureed table foods administered via enteral tube) present a superior alternative approach for this vulnerable population due to their increased viscosity, and propose an innovative randomized controlled trial to test this hypothesis. Through this career development award, I will systematically investigate the effects of blenderized diets on esophageal and gastric function, acquire expertise in food sciences to further modify and improve blenderized diets, and learn statistical techniques critical for analysis of personalized nutrition interventions.